Administration and Coordination Core (ACC)

Abstract- Administration and Coordination Core (ACC)
The vision of this proposed Artificial Intelligence, Modeling, and Informatics for Nutrition Guidance and
Systems (AIMINGS) Center is to implement computational and data science approaches and tools to
advance nutrition for precision health in a way that accounts for the complex systems involved. This
involves a deep understanding of all of the factors and processes that affect different people's dietary
behaviors and intake, absorption and processing of different nutrients, resulting in short- and long-term health
outcomes, and the way each of these affect one another. Without assistance, it can be challenging to
understand and address complex systems like nutrition and health. Cause-and-effect relationships cross
different scales (e.g., cellular-level, organ-level, individual-level, social-and-environmental level), have various
feedback loops, and evolve over time. Over the past two decades, computational power and data science have
grown substantially. Used correctly, computational approaches can help fill in important gaps, lay out causal
relationships, bring them together, and better characterize the system of nutrition; however, used incorrectly,
such approaches can result in misleading insights that may incorporate biases and worsen existing disparities.
Understanding and addressing complex systems requires both top-down and bottoms-up approaches. Using
top-down approaches alone can lead to misconceptions and bias. In contrast, bottoms-up approaches work to
rebuild the system by elucidating the mechanisms involved. The AIMINGS Center will aim to advance
nutrition for precision health by building both top-down and bottoms-up approaches and tools to
leverage existing data to its full potential. Such an approach could not only transform nutritional research
and guidance but also do so with other areas of health. Many major health and public health problems are the
result of broken systems and thus require more systems approaches to come up with more sustainable
solutions. Aim 1 of the Administration and Coordination Core is to coordinate the Center operations to develop
both top-down and bottoms-up computational approaches and tools to better understand and address the
systems involved in precision nutrition in an ethical and unbiased manner. Aim 2 is to coordinate between the
Center and across the Nutrition for Precision Health (NPH) consortium to develop shared approaches and
procedures to advance the goals of the research program (e.g., developing protocols to work with data in an
ethical and transparent manner, developing procedures and generating artificial intelligence-ready datasets).
Aim 3 is to implement a Pilot Grant Program to expand the community of researchers and stakeholders who
are working on computational approaches to understand complex data and systems in precision nutrition in an
ethical manner. Aim 4 is to catalyze the broader development and use of computational methods and tools
that help better understand and approach the systems that affect and are affected by nutrition in as ethical and
unbiased manners as possible.